Baylor College of Medicine Cancer Center-Cancer Center Support Grant

Kaposi sarcoma (KS) is by far the most common malignancy associated with human herpesvirus-8 (HHV-8)/KS-associated herpesvirus (KSHV) infection and ranks among the most common overall childhood cancers in sub-Saharan Africa. Over the past decade, our pediatric HIV malignancy program at the Baylor International Pediatric AIDS Initiative at Texas Children's Hospital/Global HOPE (Hematology-Oncology Pediatric Excellence) Clinical Center of Excellence in Lilongwe, Malawi has cared for over 200 children with KS. Our work has highlighted the clinical characteristics that render childhood KS distinct from adult disease, defined the heterogeneity in disease presentation specific to pediatrics, and established risk-stratified treatment regimens that have improved long-term survival. Long-term complete remission and event-free survival can be achieved, especially in children with lymphadenopathic KS. In stark contrast, patients with advanced visceral or disseminated disease experience high mortality rates despite intensified chemotherapeutic approaches. We have also identified associations between clinical sub-groups and KSHV-mediated mechanisms of KS oncogenesis specific to childhood disease. However, there remains a gap in knowledge concerning the inherent pathogenic mechanisms of KS. The proposed study seeks to define somatic genetic alterations of pediatric KS and determine correlations with clinical and virologic features through analysis of tumor specimens from the largest existing biocohort of childhood KS patients (n=70) from Lilongwe, Malawi. Through improved understanding of the molecular features of pediatric KS, we aim to discover biomarkers and targetable pathways that may inform the development of novel diagnostic, prognostic and therapeutic strategies.

Public health relevance
Dan L Duncan Comprehensive Cancer Center at Baylor College of Medicine OVERALL - PROJECT NARRATIVE Cancer is a leading cause of morbidity and mortality in the United States and globally. The diagnosis and treatment of cancer are extraordinarily demanding and increasingly expensive with major impacts on our economy. Although overall survival from cancer has improved and certain cancers can be prevented or cured, much remains to be accomplished to improve patient outcome through research to develop novel strategies to prevent, diagnose early, and effectively treat this disease. The Dan L Duncan Comprehensive Cancer Center at Baylor College of Medicine has put together a strong multidisciplinary team of scientists, clinicians, educators, and community outreach experts to further improve survival from cancer both in our Catchment Area and globally, and to educate the scientists and clinicians of the future.